Earliest predictors of language outcomes in high-risk infants

One in every nine babies in the US is born preterm. Speech, language and hearing disorders
(SLD) are among the most prevalent neurodevelopmental disorders in children, especially
among very preterm survivors. About 40% of very preterm infants (≤32 weeks gestational age)
develop speech-language disorders while 10% have permanent hearing loss, increasing the
impact on communication difficulties. Currently, it is not possible to accurately predict in the first
several years of life which children will develop speech-language disorders, and speech-
language therapy is the most delayed of any intervention provided to preterm infants. Such an
advance would facilitate early intervention and research therapies during critical windows of
optimal neuroplasticity. Our central hypothesis is that prediction of speech-language disorders is
possible by 3 m corrected age (CA) with combined innovative measures of structural and
functional brain connectivity with magnetic resonance imaging, evoked response measures of
speech processing, and novel, sensitized hearing measures. Primary aims are to (1) Identify
biomarkers of brain connectivity deficits in very preterm infants that predict SLD; (2) Identify
impaired speech processing and all degrees of hearing loss in very preterm infants; and (3)
Develop predictive models using advanced biomarkers in preterm infants for adverse speech,
language and pre-literacy outcomes at 2 and 3 years CA. This proposal will enroll very preterm
infants in a prospective study that will complete comprehensive speech-language and pre-
literacy assessments at 2 and 3 years CA. and 36 m CA. The overarching goal is to develop a
robust prediction model using innovative measures to enable early identification of children at
high risk for SLD.

Public health relevance
Speech-language disorders occur in 40% of very preterm infants, while 10% have permanent hearing loss. Neonatal hearing screening and cochlear implantation within the first few months have demonstrated the extreme plasticity of the developing infant brain, but speech-language disorders are typically not detected or treated before 3 years of age. The goal of this study is to use advanced measures of brain connectivity, sensitized hearing assessment, and speech evoked EEG at birth to predict infants at risk for speech-language disorders so they can start receiving intervention within the critical first year.